ALLIGNED SEGMENT STATISTICAL EVALUATION TOOL--ASSET

This is a continuation of a project to develop an efficient depth-first search algorithm for detecting patterns in molecular sequences (see last year's annual report). The method has been enhanced in several ways as follows: (i) a rigorous statistical test has been added to the procedure for grouping related patterns and identifying regions sharing a common motif; (ii) the method has been modified to allow DNA and RNA pattern searches; and (iii) a procedure has been developed to down weight redundant sequences (that is, sequences sharing significant similarity with other sequences in the input set). In addition, the method has been incorporated into a new procedure (called PASS) for semiautomatic construction of a protein motif database. The basic method has been implemented in a C language program called ASSET which has been made available via anonymous ftp. The utility of the program was demonstrated on several difficult test problems including detection of the dinucleotide-binding fold present in a small subset of 91 distantly related and unrelated proteins, detection of the helix-turn- helix motif in 15 distantly related DNA binding proteins, and the discovery of novel ankyrin-like repeats in a bacterial protein. The significance of the project lies in the development of a fast and sensitive pattern detection method as an aid to the characterization and classification of protein and nucleic acid sequences.